Non-invasive Excitation and Inhibition of Neural Activity via On-Demand Magnetothermal Drug Release

Project Summary/Abstract
Cell-type specific manipulation of neural circuits is required for the treatment of neurological disorders such as
epilepsy and Parkinson’s disease. Precise control of neural circuits will enable the development of
neuromodulation therapies for these debilitating conditions. Existing technologies to control neural activity offer
limited possibilities. Manipulation of brain circuits via direct drug treatment is restricted by the selective
permeability of the blood-brain barrier, the rapid clearance of cerebral fluids and the lack of specificity which
results in poor response to drugs and undesirable side effects. Electrical stimulation and optogenetics have open
the possibility of repairing neural dysfunction through direct control of brain circuit dynamics. However, both
technologies require implantable devices that are damaging to biological tissues. Recently, the heat dissipation
by nanomaterials, particularly magnetic nanoparticles (MNPs) and plasmonic nanostructures, has been
proposed for the wireless control of cellular signaling using external stimuli. The weak magnetic properties and
low electrical conductivity of tissue allow alternating magnetic fields (AMFs) to reach deep into the body, making
hysteresis heating of MNPs particularly promising for the treatment of brain disorders. This research grant will
develop a novel wireless pharmacological brain stimulation approach that depends on magnetic
nanoparticles (MNPs) heating effects to release neuromodulatory compounds from temperature-sensitive
polymers grafted on the surface of MNPs. The developed technology will be suitable for drug release in multiple
on-demand dosages, which it is required for neural activity stimulation. Additionally, we will tailor polymer
surface chemistry for the combinatorial release of neurostimulator-inhibitor pairs to allow modulation of brain
circuit signals. Preliminary results demonstrate: 1) the heat dissipated by MNPs under AMFs is sufficient for the
rapid and complete release of a payload from MNP surfaces, 2) MNPs targeting to neuronal membranes via
antibody specificity, followed by magnetothermal drug treatment that allows for one-time excitation of neural
activity, and 3) the precise control of polymer growth from the surface of MNPs. This research grant drives new
advances in stimuli-responsive hybrid nanoparticle systems for the pharmacological modulation of neural activity.
Wireless magnetothermal release of dopamine and chlorpromazine from polymer coated MNPs is expected to
excite and inhibit activity of dopaminergic neurons. This system will be optimized for on-demand multiple
dosages release by triggering heat response with AMFs. Finally, the functional properties of clinically-relevant
neural modulation by magnetothermal drug release will be evaluated through in vitro assays. Magnetothermal
modulation of neural activity shows considerable promise as a powerful pharmacological technology that can be
applied to restore brain functions, and in single-cell manipulation settings for the better understanding of neural
circuits. Future directions of this work include the development of a magnetothermal platform that allow in vivo
pharmacological modulation of neural activity.

Public health relevance
PROJECT NARRATIVE This project develops a transgene-free, minimally invasive and cell-type specific pharmacological alternative for neuromodulation therapies. This approach promises the wireless and precise control of neural activity by delivering locally excitatory and inhibitory compounds, which is not possible to achieve by conventional neuromodulation treatments. This technology is also expected to establish a new platform for mapping brain circuits to improve our understanding of complex neural networks.